Pomegranate Extract and Its Microbial Metabolite Urolithin A Suppress IBD through Modulation of the Gut Microbiome and T Cell Inflammatory Immune Responses

The prevalence of inflammatory bowel disease (IBD), such as Crohn’s disease and ulcerative colitis, is increasing
in Veterans. Diet plays an important role in shaping the intestinal microbiota and has emerged as an important
and actionable modifier of IBD. In addition, metabolites derived from nutrients by gut bacteria have been shown
to modify IBD progression. For example, pomegranate ellagitannins (ET) are broken down to ellagic acid (EA)
and further converted to urolithins by gut bacteria. Both EA and UA were demonstrated to improve symptoms of
IBD in chemically induced mouse models of colitis. We have recently shown that dietary pomegranate extract
(PomX) supplementation reduced colitis markers and downregulated colitis associated inflammatory pathways
in IL-10-/- mice. We also found that PomX and UA reduced pathobionts in wildtype mice. In addition, inter-
individual variations in urolithin production, so called metabotypes (A: only produce UA, B: forms urolithin B (UB),
or isoUA; 0: do not form any urolithins) have been well documented and associated with individual’s metabolic
health. It is our hypothesis that dietary PomX and/or UA suppress IBD pathogenesis by changing the gut
microbiome, strengthening the gut barrier integrity and inhibiting the differentiation of Th1 and Th17 intestinal T
cells and pro-inflammatory cytokine. Therefore, we propose to investigate whether dietary supplementation with
PomX and/or UA will prevent or alleviate colitis and to identify the mechanisms involved in PomX/UA-induced
suppression of colonic inflammatory pathways. The IL-10-/- mouse model, which mirrors the multifactorial nature
of IBD, is ideal to investigate the effect of dietary supplementation on colitis. To accomplish this, in aim 1 we will
investigate the effect of PomX in suppressing spontaneous colitis development in IL-10-/- mice, which either
produce UA (metabotye A) naturally, or lack bacteria forming UA (metabotype 0). We will also evaluate whether
UA will enhance PomX effects in metabotype 0 mice. Last, we will interrogate the potential mechanism of action
of PomX and/or UA supplementation on gut microbiome and host immunity by performing fecal shotgun
metagenomics sequencing, fecal and blood metabolomics, colonic tissue snRNAseq, cytokine RTqPCR, tissue
tight junction analysis and immune cell phenotyping in IL-10-/- mice receiving dietary PomX and/or UA. In aim 2,
we will investigate whether PomX and/or UA induced changes in the gut microbiome are responsible for their
effect on colitis suppression in IL-10-/- mice. Gnotobiotic IL10-/-mice will be colonized with naïve, or PomX,
and/or UA treated gut microbiome from human donors (metabotype A and B), and fed a high fat/high sucrose
(HFHS) diet for 12 weeks. We will investigate the role of donor microbiome metabotype to PomX treatment could
play in colitis susceptibility. In aim 3, we will evaluate the effects of PomX and/or UA on the intestinal T cell-
mediated immune inflammatory pathways associated with colitis. Rag1-/- mice will be pre-treated with dietary
PomX and/or UA and then injected intraperitoneally with CD4 naïve cells isolated from wildtype mice. After the
T cell transfer the mice will undergo the dietary intervention for 12 weeks and their course of colitis will be
compared to mice fed the HFHS diet. To establish whether PomX and/or UA effects are mediated through the
modulation of the microbiome or not, in vitro studies utilizing primary CD4+ cell lines will be used to evaluate
PomX and/or UA direct effects on TCR activated CD4+ cell phenotype, and on the proliferative, signaling and
cytokine responses. Our proposed research presents a novel approach using dietary PomX/UA to prevent or
attenuate colitis by targeting the intestinal microenvironment, created by bacteria and their metabolites leading
to selective interaction with the host immune system. Results from these preclinical studies will lay important
groundwork for future clinical studies to explore the use of dietary PomX/UA supplements as alternative and
adjuvant therapy to improve gut mucosa inflammation or alleviate relapse in IBD, thus reducing immune-
suppressing medications to a minimum in patients with mild to moderately active IBD.

Public health relevance
Inflammatory bowel diseases (IBD) affect Veterans at a disproportionate rate. IBD results from a complex interaction among the patient’s intestinal tract, gut microbiota and environmental factors such as diet. Pomegranate extract (PomX) and its gut microbiome metabolite urolithin A (UA) decreased the abundance of pathogens associated with IBD and reduced intestinal inflammation. Individual’s capability of producing UA depends on his/her gut microbiota. Furthermore, the capability is linked with chronic disease risks that may determines individual response to diet intervention. Therefore, we are proposing to evaluate the efficacy of PomX in reducing IBD symptoms in mice with and without UA producing capability separately. Results from our studies will be a premise for future clinical studies to explore the use of dietary PomX/UA supplements as alternative and adjuvant therapy based on individual gut microbiome status to improve gut mucosa inflammation in IBD, thus reduce the use of immune-suppressing medications in patients with mild to moderately active IBD.